An effective statistical inference framework to develop innovative compensations for protein mutations

Understanding protein mutations requires learning which specific mutations disrupt a protein's function and offers the
opportunity to further understand how to restore the normal function by introducing additional mutations. The approach
here builds upon analyzing the huge protein sequence and structure data with two novel statistical frameworks, including
high-dimensional Potts model inference with structure information, and inference on matrix-valued partial correlations,
to develop quantitative predictions of which mutants disrupt function with a new uncertainty measure and models the
mutation finesses by integrating the sequence and structure data. Together these innovative approaches with the
uncertainty quantification will enable the prediction of compensatory mutations and the final construction of a protein
mutant atlas that broadly disseminates the collective mutation information. The project will learn which mutants disrupt
protein function, and what additional mutants will restore function. This project will demystify the interdependencies
within the sequences to yield a deeper understanding of how protein mutations can change phenotypes. Preliminary
results demonstrate how mutations that are intrinsically destabilizing, and destructive can persist but be neutralized by
the introduction of additional compensatory mutations. The major aims of this project are to reliably distinguish
between the neutral and deleterious mutations and learn how to repair these problems by introducing additional
compensating mutations, by applying the new statistical inference frameworks. The tools developed in this project will
have the power to make direct connections between gene mutations and changes in phenotypes. This is a highly
interdisciplinary collaboration essential for establishing meaningful assessments of protein mutations and that will
develop an important tool for informed protein editing.

Public health relevance
RELEVANCE (See instructions): The foundations built in this project will enable reliable ways to directly lead to the meaningful interpretation of the hidden information buried in genomic and proteomic sequences. Predicting compensatory mutations, where mutations in one part of a protein compensate for damaging mutations in other parts will likewise provide a rational basis for gene editing, as well as understanding of evolution. This ambitious project aims to broadly identify which gene mutations are damaging and how to counteract their effects with the new unique open-source computational tools.